A novel family of conserved glyoxal toxicity response proteins.

Advanced Glycan End Products (AGEs) are toxic and highly reactive dicarbonyl molecules
produced by most life on earth from routine metabolic processes. As such, conserved and
dedicated detoxifying systems have emerged for dicarbonyl removal. Owing to their importance,
these removal systems are required to maintain longevity, thereby emphasizing the importance
of dicarbonyl detoxification in maintaining health. One of the most prominent dicarbonyl species
is glyoxal, which is predominantly produced as a byproduct of glycolysis. Glyoxal acts by
mounting specific attacks on certain amino acids, namely arginines, cysteines, histidines and
lysines in key proteins, thereby adversely altering protein function. In humans, these
modifications can result in many diseased states, including: cancer, diabetes, nervous system
disorders, heart disease, hypertension, atherosclerosis and aging. Unfortunately, although
dicarbonyl stress-related toxicity is now regarded as important as oxidative stress, knowledge
about how cells are able to detect and respond to glyoxal buildup is, by comparison, severely
lacking. Our lab has discovered a novel class of Antibiotic Monooxygenase (ABM) domains that
we hypothesize sense and respond to glyoxal and related dicarbonyls from bacteria to humans.
This project proposes to elucidate the mechanism by which one of these ABM domains, we
named Glyoxal-ABM Domain 1 (GAD1) responds to glyoxal in the bacterial pathogen
Pseudomonas aeruginosa. We have thus far shown that GAD1 from P. aeruginosa, which is co-
transcribed with the glyoxal detoxification enzyme GloA2, binds heme directly and is also
covalently modified by glyoxal on a conserved arginine residue (Arg49). We hypothesize that
GAD1 and its many homologs are specifically modified on conserved residues, which, in turn,
signals to switch cellular metabolic flux away from glycolysis other pathways unable to produce
the glyoxal toxin. Our studies here will Aim to (1) map GAD1 regulation, (2) determine its cellular
distribution and its interactome and (3) solve the structures of its apo and holo forms, and in
complex with interacting partners in P. aeruginosa. Studying GAD1 in P. aeruginosa is expected
to reveal novel pathways that have potential as new antimicrobial targets, and at the same time
advance our basic understanding of glyoxal toxicity sensing in humans and other multicellular
organisms.

Public health relevance
Project Narrative This grant aims to understand the molecular and regulatory details of how a novel and conserved subfamily of heme-binding proteins responds to glyoxal-related toxicity. The data derived from this work is expected to shed light on the understudied area of glyoxal induced cellular stress, and how it regulates cellular metabolic changes and disease.